Silencing B7-H3 mitigates tumor aggressiveness in group 3 medulloblastoma

PROJECT SUMMARY/ABSTRACT
Medulloblastoma (MB) is the leading cause of cancer-related mortality in childhood. Divided into four
subgroups, patients with group 3 tumors (G3MB) have the lowest survival rate (<50% at 5 years). This has been
attributed to a lack of targeted therapies and high-risk features, like deletions along the short arm of chromosome
17. These deletions target critical tumor suppressor genes like miR-1253, a brain-enriched microRNA active
during cerebellar development. Restoring miR-1253 expression in G3MB cell lines reduced cancer cell growth
and aggressiveness, inhibiting several oncoproteins, including B7-H3, which has been strongly linked with
metastasis and immune evasion in many aggressive cancers. Silencing B7-H3 expression in G3MB cells
dramatically reduced their growth and invasiveness, as well as the expression of SLUG, a JAK2/STAT3 signaling
product associated with metastasis.
This kindled our interest in finding drug compounds to silence B7-H3 signaling as a novel way to treat G3MB
tumors. By screening an extensive collection of molecules known to interact with B7-H3, one highly potent
compound, B7-H3-Ni1 (Ni1), was identified, which inhibited G3MB cancer cell viability at low micromolar
concentrations. The overall objective of this proposal is to demonstrate a mechanistic proof-of-concept for B7-
H3 inhibition as a therapeutic approach against G3MB. We hypothesize that B7-H3-Ni1 can suppress G3MB
tumor growth and aggressiveness by activating immune cell function and inhibiting JAK/STAT signaling
pathways associated with metastasis.
In Aim 1, we will map the molecular binding of Ni1 to B7-H3. For immune activation, a syngeneic G3MB cell
line (MP-1) co-cultured with mouse Tregs, CTLs, or NK cells will be treated with vehicle, Ni1, or si-B7-H3 to study
the effect of B7-H3 blockade on immune cell degranulation, target cell lysis, cytokine production, and cancer cell
viability. For JAK2/STAT3 signaling, we will measure the impact of vehicle vs. Ni1 vs. si-B7-H3 on metastasis-
associated signaling partners of B7-H3, metastasis-associated effectors of JAK2/STAT3 signaling, and apoptotic
markers. Impact on cancer cell growth, viability, and invasiveness will also be assessed in vitro. Then, we will
examine if Ni1 signaling is enhanced by a STAT3 inhibitor (WP1066). A B7-H3 knockout (B7-H3KO) G3MB cell
line will be incorporated into all in vitro studies. In Aim 2, an immunocompetent G3MB mouse model that most
closely recapitulates human disease will be used to illustrate the immunostimulatory and anti-neoplastic
properties of Ni1. We expect to demonstrate that treatment with Ni mitigates tumor burden and longevity by
downregulating JAK2/STAT3-associated metastasis signaling. At completion, our studies will address a critical
gap for G3MB patients who suffer disproportionately high mortality rates amongst MB patients by characterizing
a novel anti-tumor agent that may be efficacious and well-tolerated. By identifying a new druggable target (B7-
H3), we may unlock the potential to transform the treatment of advanced MB tumors.

Public health relevance
PROJECT NARRATIVE The enrichment of B7-H3 has been linked to an invasive and immune evasive phenotype in many aggressive cancers, including group 3 medulloblastomas (G3MBs). The aim of this proposal is to investigate the anti- neoplastic properties of a new B7-H3 inhibitor (B7-H3-Ni1) by identifying which intracellular deregulated signaling pathways are silenced and how the immune system is activated by B7-H3 inhibition. The goal is to use this mechanism and demonstrate a reduction in tumor burden and improvement in outcomes of G3MB tumors in an immunocompetent transgenic mouse model.